A gaze-controlled neck exoskeleton for dropped head syndrome

PROJECT SUMMARY
Although static neck braces are prescribed to patients with dropped head syndrome, a condition that results
from diverse causes (e.g., amyotrophic lateral sclerosis), many patients do not use these neck braces because
they are static, uncomfortable, and ineffective. As a result, patients leave their head drop condition untreated,
which worsens their ability to breathe, swallow, speak, and perform other daily tasks. The long-term goal is to
treat dropped head syndrome by restoring head-neck motions through an at-home, personalized, and easy-to-
use wearable robotic solution (e.g., neck exoskeleton). The overall objective in this application is to determine
general models to predict head-neck movements in different gaze conditions (e.g., smooth pursuit, saccade)
and a personalization strategy for a gaze-controlled neck exoskeleton in people with dropped head syndrome.
The central hypothesis is that eye movements can reliably predict head movements in diverse situations and that
preferences of people with dropped head syndrome can be learned via minimal and accessible human-robot
interaction, leading to personalized control strategies for the neck exoskeleton. The rationale for this project is
that a determination of effectiveness of predictive models and associated personalization strategies using eye
gaze is likely to offer a powerful scientific platform for future development in neck exoskeletons and transla-
tional trials in people with dropped head syndrome. The central hypothesis will be tested by pursuing two
specific aims: 1) Identify predictive model(s) of head-neck motions using gaze; and 2) Determine a personaliza-
tion strategy for gaze control in people with dropped head syndrome. Under the first aim, head-eye behaviors
will be observed in virtual environments and the data will be used to create models that predict head-neck
motions using eye movements for diverse gaze behaviors (e.g., smooth pursuit, saccade). For the second aim,
three proposed personalization algorithms will be developed and evaluated in a user study to determine the
most effective strategy for personalizing gaze-control of a neck exoskeleton for patients with dropped head
syndrome. The research proposed in this application is innovative, in the applicants’ opinion, because it focuses
on achieving an easy-to-use control through user’s natural gaze behavior and a continued human-in-the-loop
personalization strategy. The proposed research is significant because it is expected to provide strong scientific
justification for continued development of the gaze-controlled neck exoskeleton and future clinical trials that
are aimed to eventually translate the neck exoskeleton technology to use at patients’ homes. Ultimately, such
knowledge has the potential of offering new opportunities for better treatment for dropped head syndrome.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the proposed gaze-controlled neck exoskeleton and its associated personalization strategy have the potential to improve care and quality of life for people with dropped head syndrome, a condition caused by diverse diseases such as neurological disorders and autoim- mune conditions. This project is relevant to the part of the NIBIB’s mission that pertains to developing biomedical technologies to improve health and medical care.